Biostatistics, Epidemiology, and Research Design

PROJECT SUMMARY / ABSTRACT
The Biostatistics, Epidemiology, and Research Design (BERD) core is a required component of
Mountain West Clinical and Translational Research Infrastructure Network (MW CTR-IN). BERD
provides data analytic support essential to clinical and translational research within the CTR-IN
network of 13 public universities in seven mountain west states. Consisting of a network of 13
sites, BERD supports research projects throughout their life course by ensuring valid study
designs, appropriate data acquisition, effective data analyses, and objective data interpretation
while continues to expand its technical capacity through training and development. In particular
BERD will expand its capacity to focus on supporting multisite studies of health disparities in the
region and supporting studies that leverage national databases and bioinformatics. BERD will
achieve its goal through a list of specific aims and associated activities:
1. Continue to provide accessible, high-quality services and collaboration in biostatistics,
epidemiology, and research design to investigators throughout the 13 member institutions of
the MW CTR-IN. BERD will campaign the model of Design-to-Dissemination (D2D) to
enhance engagement with investigators throughout the life course of a research project,
thereby enhancing team science.
2. Expand the capacity of, and provide technical assistance in, data coordination to support
cross-site data needs in the expansion of multisite studies. This initiative will operationalize
seamless implementation of data collection, management, analyses, and dissemination to
support priority research such as health disparities.
2a. Offer access both to data coordinating capacity currently in operation at the University of
New Mexico (UNM) and to technical assistance to help expand and leverage data coordinating
infrastructure already existing at other MW CTR-IN sites.
2b. Develop and apply specialized study designs, tools, and biostatistical methods to address
challenges arising from current and emerging studies.
3. Provide training to disseminate current and classical biostatistics in response to emerging
needs at the MW CTR-IN, particularly those related to:
3a. Emerging priority research such as health disparities.
3b. Technical capacity for leveraging large databases and in bioinformatics within BERD.

Public health relevance
PROJECT NARRATIVE The Biostatistics, Epidemiology, and Research Design (BERD) core of MW CTR-IN provides data analytic support essential to clinical and translational research throughout the life course of a project. The BERD support is critical in ensuring valid study designs, appropriate data acquisition, effective data analyses, and objective data interpretation. BERD will also expands its capacity to focus on supporting health disparities research in the mountain west states the MW CTR-IN serves.